LSUHSC COBRE: CORE 6: PROTEOMICS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The LSUHSC Proteomics Core Facility, supported by this COBRE, the LSUHSC School of Medicine, the Louisiana Cancer Research Consortium, offers proteomic services and resources to investigators both within and outside of LSUHSC. The facility personnel consult in the design and implementation of experiments for the advancement of investigators'projects. The main laboratory occupies ~1300 sq. ft. of laboratory space to house several advanced mass spectrometers, 2-Diminsional gel electrophoresis and 2-Diminsional Liquid Chromatography. An additional 500 sq. ft. of laboratory space is dedicated to 2-Dimensional gel electrophoresis. The Proteomics Core Facility is highly experienced in protein extractions from cells and tissues for 2DGE. Currently, the new generation fluorescence-tag based 2DGE, different gel electrophoresis (DiGE), is the choice of the Facility. DiGE eliminates gel variations by running differentially tagged control and treated samples in the same gel. The uniquely labeled protein samples are separated using an IPGphor IEF and a Dalt6 PAGE cell from GE Healthcare. Following electrophoresis, a GE 9400 Typhoon scanner image is analyzed with DeCyder image analysis software. This software provides investigators with statistically accurate and sensitive protein quantification. A GE Ettan spot handling workstation cuts and digests gel spots automatically for sequential protein identification by mass spectrometry. In addition, traditional 2-dimensional gel electrophoresis utilizing the Bio-Rad system (PDQuest software, ProteomeWorks spot cutter and GS800 scanner from Bio-Rad and MultiProbe spot handling system from Perkin-Elmer) is also offered for investigators when needed.